Structural Basis of Signal Instigation Through Family C GPCRs

Abstract
The γ-aminobutyric acid B receptor (GABABR) and the metabotropic glutamate receptors (mGluRs) belong to
the Family C of G protein coupled receptors (GPCRs) and critically regulate neuronal excitability, synaptic
transmission and plasticity. Many disorders of the CNS have been linked to alterations in neuronal excitability
via the glutamatergic and GABAergic system. Accordingly, mGluRs and GABABR have been the subject of an
enormous drug discovery effort as they represent major therapeutic targets for treating numerous physiological
dysfunctions and for neurodegenerative and neuropsychiatric conditions. Apart from the prototypical seven
transmembrane helix (7TM) domain, Family C GPCRs also include a large extracellular ‘venus fly trap’ (VFT)
domain that constitutes the orthosteric ligand binding site. Binding of ligand to the extracellular VFT domain
triggers a large conformational change in the VFT domains from an open to a closed conformation. This clam-
shell like closure of the extracellular domain results in receptor engagement and activation of G proteins on the
intracellular side of the transmembrane domain with a mechanism that remains unclear. Receptor activated G
proteins then act to either enhance or repress secondary messenger signaling cascades. We recently showed
cryoEM structures of near-full length mGluR5 and GABABR in inactive and active conformations, revealing
extensive transitions in the organization of the 7TM dimer upon ligand binding to the VFT. Notwithstanding this
progress, several key questions remain regarding the allosteric communication across the cell membrane by
Family C GPCRs, and particularly the mechanism of G protein coupling and activation. To address these
questions, we propose to obtain the structures of mGluR2, mGluR5 and GABABR in complex with their cognate
G proteins and probe the structural insights using molecular dynamics simulations and mutagenesis coupled to
functional assays. The similarities and differences amongst these receptor-G protein complexes will allow us to
contrast and compare our findings and examine aspects of G protein coupling and selectivity. Collectively,
these studies will enable us to create a detailed mechanistic framework to understand Family C GPCR
signaling and will form the basis for the design of novel therapeutic strategies targeting these receptors.

Public health relevance
Narrative The binding of glutamate to metabotropic glutamate receptors (mGluRs) and of g-aminobutyric acid (GABA) to GABAB receptors drives signaling cascades that start with G protein binding to the intracellular side of the receptor. We propose to obtain the cryo-electron microscopy (cryo-EM) structures of mGluR2, mGluR5 and GABAB receptor in complex with their G protein partners and interrogate the signaling mechanism with in vitro assays and molecular dynamics (MD) simulations. As defects in glutamatergic and GABAergic signaling are linked to many neurological conditions such as Parkinson's disease, schizophrenia, drug addiction, depression, and pain, this knowledge will be ultimately used for the design of novel therapeutic strategies to combat these disorders.